Discovering Infection-mediated Pathways of Glioma Etiology and Prognosis by Leveraging Multiplex Serology and Immunogenomics

PROJECT SUMMARY
Gliomas account for 80% of all malignant brain tumors and have an extremely poor prognosis, with a 5-year
survival of 5.1%. The etiology of glioma remains poorly understood, with few established modifiable risk factors.
Multiple studies have implicated infections in the development of glioma, however the underlying mechanisms
and putative causal pathogens remain unclear. In addition to risk, there is also accumulating evidence from
studies investigating novel therapeutics suggesting that immune response to infection may be prognostic in
glioma patients. Previous epidemiologic studies have investigated a limited number of pathogens using
serological assays that only allowed detection. We seek to conduct a large serologic study measuring 41
antigens from all 12 infections previously associated with glioma using assays that provide quantitative measures
of antibody response. Our study will include 1000 glioma case-control pairs with extensive clinical and
epidemiologic data. In Aim 1 we will estimate the effect of each individual infection on glioma risk and survival
and also examine grouped patterns of co-infections. In Aim 2, we will employ innovative long read sequencing
technology to detail all polymorphisms in human leukocyte antigen (HLA) class I and II genes in the same set of
subjects. Genetic variation in the HLA region plays a pivotal role in regulating immune response to viral challenge
and has been previously linked to glioma risk and progression. We will investigate a range of functional HLA
polymorphisms, including antigen-presenting classical alleles and amino acid residues, with respect to glioma
risk and survival. In Aim 3, we will integrate serological and HLA sequencing data to delineate host genetic
mechanisms of immune response to infection and subsequent effects on glioma endpoints. This will allow us to
develop comprehensive immunogenomic models for predicting glioma risk and survival. Taken together, the
proposed study will contribute new, high-quality data that will significantly advance our understanding of glioma
pathogenesis, as well as inform avenues for prevention and improvement of outcomes in glioma patients.

Public health relevance
PROJECT NARRATIVE Glioma has been associated with a number of infections. We will examine antigen reactivity to all infections previously linked with glioma to assess the risk and survival associated with each of these infections and groups of co-infections. We will then sequence an area of the genome that controls immune response to determine which genetic alterations interact with infections, and how infections and genetics together alter risk and survival of glioma.